Infant Neural Processing of Sound TALK Administrative Supplement

ABSTRACT
This is an application to NOSI NOT-DC-23-005 for one year of supplemental funding to enhance language
assessment and to increase the impact of our ongoing project, the Development of the Neural Processing of
Sound in Infancy. In this supplement, we propose adding a 30-month timepoint to our existing longitudinal study
with a focus on language assessment. Our presently funded study involves brain measures of speech and pitch
processing using magneto-/electroencephalography in combination with a behavioral assay of cross-domain
development including language abilities, auditory skills, vocabulary, and adaptive behaviors, obtained at 3-, 6-,
and 11-months in infants with and without hearing loss. This proposed work falls within the scope of the funded
aims as the study seeks to investigate auditory brain development in the context of hearing ability and language
skills. Importantly, this supplement would add a later timepoint, after which late talkers can be identified. Thus,
significantly enhancing our ability to characterize early language learning trajectories in tandem with early brain
measures of sound processing. We expect hard-of-hearing infants to be at an increased likelihood of late
language emergence in addition to 10-20% of our typical hearing (TH) participant sample. Moreover, while most
TH participants may not reach late talker criteria, we expect a wide range of language abilities in his cohort. This
additional 30-month timepoint, will allow us to expand on our prior aims to identify early brain and behavioral
predictors of language outcomes. As we have longitudinal brain measures in combination with both parent-report
and direct developmental assessments administered with infants in the laboratory, we are uniquely able to
compare objective brain measures to clinically relevant measures of language development longitudinally from
3 months. Current language screening tools are often administered between 18 to 24 months or even later.
However, prior studies show that starting intervention programs earlier, such as in the first year of life, leads to
more optimal language and learning outcomes. This proposed research has the potential to reveal early brain
and behavioral markers of language delay and advance our understanding of whether language screening in the
in the first year of life is clinically useful. If successful, these results can lead to improved identification of infants
at a higher likelihood of late language emergence, allowing for earlier intervention and prevention. The PI is a
developmental auditory neuroscientist and a pediatric speech-language pathologist that has expertise in
language assessment in the zero-to-three population in both research and clinical settings. The findings will also
serve as the basis for an R01 that extends this research to investigate early auditory brain and behavioral
markers of language outcomes in TH and HoH infants for this early-stage investigator.

Public health relevance
PROJECT NARRATIVE This administrative supplement in response to NOSI NOT-DC-23-005 will add enhanced language assessment in an additional 30-month timepoint to our ongoing longitudinal study of brain and behavioral development in infants with and without hearing loss. This supplement will enable us to identify neural and behavioral measures that best predict the trajectory of children with late language emergence in the context of their hearing abilities.